Administrative Core

Modified Project Summary/Abstract Section: Administrative Core

The Administrative Core will provide the operational structure necessary for the planning, implementation and management of all SPORE activities by providing the leadership and organizational supervision required for the efficient, progressive and successful conduct consistent with the program goals and SPORE mission.

The Administrative Core will centrally provide a wide variety of administrative coordination, oversight, and research support services to all leaders, co-leaders, investigators and core directors and offer these services in a centralized manner, to promote efficiency and ensure that all SPORE research and activities are focused, connected, complex scientific objectives are met, and existing cancer center resources are utilized and not duplicated.
The Administrative Core will also provide the oversight, monitoring and auditing required to ensure projects are meeting translational endpoints and reach a human application within five years, consistent with the SPORE mission.
Specific Aims:
1. Research - Scientific Management: Provide the operational structure necessary for managing and supporting the scientific research activities of SPORE projects, cores and development programs.
2. Monitoring and Oversight: Provide strategic oversight, monitoring and evaluation of projects, cores, and development programs to ensure scientific connection, collaboration, and translational progression.
3. Clinical Research Application: Provide the oversight, regulatory support, coordination and management for the translation of SPORE research and oversee efforts to assure accrual goals to HN SPORE clinical studies are met.
4. Regulatory Compliance: Ensure compliance with all administrative and programmatic mandates of the grant and assure data quality and compliance with regulatory requirements for clinical research.
5. Collaborations and Sharing: Facilitate translational research collaboration and oversee research resource sharing.
6. Fiscal Management: Management of SPORE budget, subcontracts, record keeping and all other fiscal activities of the grant

Modified Specific Aims Section: Administrative Core

The purpose of the Administrative (Admin) Core is to provide the scientific leadership and the operational structure necessary for the systematic collaboration, planning, implementation, management and supervision of all activities in the Wisconsin Head and Neck (HN) SPORE, for the successful performance of this grant, and in addition, provide our researchers with the resources necessary for efficient, progressive and successful conduct consistent with the program goals and HN SPORE mission. The Wisconsin HN SPORE Admin Core will coordinate with the UWCCC Shared Resource leaders for management and optimization of established comprehensive services currently offered to investigators, and provide the HN SPORE Principal Investigator, HN SPORE Administrator, Co-Leaders and Directors with an experienced infrastructure to navigate and facilitate the translational process to ensure the HN SPORE research activities are focused, connected, and complex objectives are efficiently achieved.

The specific aims of the Admin Core are:

AIM 1: Research - Scientific Management: Provide the operational structure necessary for managing and supporting the scientific research activities of HN SPORE projects, cores and development programs and provide the leadership with the resources needed to ensure effective and efficient implementation and completion of each HN SPORE objective.

AIM 2: Monitoring and Oversight: Provide strategic oversight, monitoring and evaluation of projects, cores, and pilot programs to ensure scientific connection, collaboration, and translational progression towards human application within five years.

AIM 3: Clinical Research Application: Provide the oversight, regulatory support, coordination and management for the translation of SPORE research into human application and oversee efforts to assure accrual goals to HN SPORE clinical studies are met.

AIM 4: Regulatory Compliance: Ensure compliance with all administrative and programmatic mandates of the grant and assure data quality and National, State and local regulatory standards and requirements for clinical research are met.

AIM 5: Collaborations and Sharing: Facilitate translational research collaboration within the University of Wisconsin and other HN SPOREs; ensure consistent and regular data exchange and communication between the Leaders of the projects and cores; supervise the management and sharing of data and research resource sharing; oversee communication and relations with Wisconsin communities and the public in general in regard to HN SPORE research and activities.

AIM 6: Fiscal Management: Provide management of HN SPORE budget, subcontracts, record keeping and all other fiscal activities of the grant.